Administrative Core

Abstract
The Administrative Core provides the overarching leadership that sets the tone, philosophy, and scientific
vision of the University of Washington Alzheimer's Disease Research Center (UW ADRC) for the next 5 years
and beyond. It ensures that the UW ADRC supports the needs of UW, regional, and national Alzheimer's
disease and related dementias (ADRD) investigators and their projects. It does so by providing expertise and
well-developed research resources. We enable clinical research which might not otherwise be possible to
accomplish due to the time, expense, and expertise it takes to obtain well-characterized and deeply
phenotyped human participants and the biospecimens obtained from them. The Core administers a vibrant
developmental research project program, focused on young investigators, and closely linked to the Research
Education Component. The Administrative Core situates and advocates for the ADRC in its overall institutional
setting, and optimizes its impact locally, at our university, within the Alzheimer's Disease Centers Program, and
within the broader community of investigators focused on developing solutions for ADRD. The Core also
fosters a timely and visionary collaboration with Partnerships for Native Health (P4NH) to build research
resources for investigating ADRD in American Indians and Alaska natives.